NYU Training Program in Healthcare Delivery Science and Population Health Research

Project Summary/Abstract
Objectives: New York University School of Medicine proposes to establish a research training program in
Healthcare Delivery Science and Population Health with the following aims:
1. To select and recruit highly qualified, predoctoral and postdoctoral scientists (PhD or MD) with potential to
become innovative and creative leaders in healthcare delivery science and population health research.
2. To increase trainees' knowledge, skills and motivation to pursue independent research careers at the
interface of health services research and health care delivery systems.
3. To mentor these scientists to facilitate entry in academia and transition as independent researchers.
4. To evaluate the effectiveness of the T32 Program and ensure milestones are achieved.
Rationale: Health care delivery systems have fallen short in translating evidence-based clinical and population
health interventions into practice, and have lagged in generating new evidence about optimal systems of care.
To address these problems, we need a large cohort of researchers with the methodologic skill, institutional
savvy, and social capital to bridge the gap between health services research and real-world health care
delivery systems operations.
Design: Combined, predoctoral and postdoctoral research training program in Healthcare Delivery Science and
Population Health.
Key Activities: The predoctoral trainees in each cohort will graduate with a PhD in Biostatistics, Epidemiology,
Population Health, or Systems and Computational Biomedicine. The postdoctoral trainees in each cohort will
complete a 2-year fellowship and graduate with a Master's of Science in Clinical Investigation, with a
Concentration in Healthcare Delivery Science.
Planned Duration of Appointments: 2 years for each trainee.
Number of Trainees: In each cohort, we will recruit, educate, and mentor 4 predoctoral and 5 postdoctoral
trainees: a total of 27 trainees over 5 years.
Intended Trainee Outcomes: Trainees will be followed for 10 years to measure degree completion; number of
professional presentations and peer-reviewed publications; academic and clinical leadership positions;
academic career awards; and federal and non-federal grants.
Potential Impact: This T32 Program will address a critical deficiency in the academic workforce by educating,
mentoring, and preparing healthcare delivery system scientists to pursue careers that will foster the
development and success of learning health care systems.

Public health relevance
Project Narrative New York University School of Medicine proposes to establish a predoctoral and postdoctoral interdisciplinary Training Program in Healthcare Delivery Science and Population Health. The predoctoral trainees will graduate with a PhD in Biostatistics, Epidemiology, Population Health, or Systems and Computational Biomedicine, and the postdoctoral trainees will complete a 2-year fellowship and graduate with a Master's of Science in Clinical Investigation, with a Concentration in Healthcare Delivery Science. This two-year training program is designed to prepare a cadre of scholars and future leaders who will bridge health services research and health care delivery systems to accelerate the transformation of learning health care systems.